Gene-Environment Interactions in Human Evolution and Complex Traits

Project Summary
Genetic variations, environmental exposures, and their interactions underlie the etiology of all human
diseases. While genome-wide association studies have revealed many trait-associated genetic variants
and epidemiological studies have pinpointed myriad disease-associated environmental factors, the role
of their interactions is much less explored, mainly due to the lack of very large population cohorts, high-
quality environmental measures, and efficient tools. This proposal aims to characterize gene-
environment interactions (GEI) in both human evolution and complex traits. Genetic and polygenic
adaptations to local environments during human evolution have shaped the gene-environment
relationship and the genetic architecture of complex traits. Leveraging the growing number of ancient
DNA, we will first develop and apply statistical tests to identify genetic and polygenic responses to the
Agricultural Revolution. The findings of adaptive genetic variants and polygenic traits will inform our
understanding and study of the current epidemics of complex diseases, which are likely results of
present-day gene-lifestyle mismatches. Second, to directly identify and quantify GEI in complex traits,
we will develop an efficient computational pipeline and perform large-scale interaction analysis across
the genome, phenome, and selected high-quality environmental factors in UK Biobank. All summary
statistics will be released publicly as a database on a dedicated website to fuel further explorations,
such as meta-analysis and testing for replicability across cohorts and ancestries. Third, to assist and
guide future GEI studies, we will develop the first bioinformatics tool for phenome-wide interaction study
(PheWIS) of target genetic variants and environmental exposures, enabling efficient and unbiased
search for environment-modifiable phenotypic effects. Moreover, to alleviate the multiple testing burden
in GEI studies with a large number of exposures and clinical outcomes, we will examine if Mendelian
randomization analysis coupled with phenome-wide association study (PheWAS-MR) could be an
effective way to prioritize potentially causal exposure-outcome relationships, which may increase the
statistical power of detecting GEI and assist the downstream search for functional mechanisms. Lastly,
as an effort to improve the portability of polygenic score (PGS) across ancestries and subgroups with
the same ancestry, we will use simulated and empirical data to test if explicit statistical modeling of GEI
could mitigate the problem. Concurrently, we will examine if PGS-environment interaction analysis is
an effective approach to identify actionable environmental exposures that attenuate genetic risks.
Overall, this proposed research will generate new methods, computational tools, database resources,
and novel insights into the general patterns of GEI in human complex traits.

Public health relevance
Project Narrative This proposal aims to characterize gene-environment interactions (i.e., genetic effects modified by environment) underlying complex traits in humans. We will develop statistical tests to identify historical genetic responses to the Agricultural Revolution during human evolution, which will inform our understanding and study of the current epidemics of complex diseases because they are likely results of gene-lifestyle mismatches. We will develop computational tools and perform large-scale empirical analysis in large population cohorts to characterize gene-environment interactions, to prioritize actionable environmental exposures for clinical intervention, and to improve genetic prediction for precision medicine.